Histamine in homes: Exposure risks and health effects

Exposure to indoor environmental contaminants is a major health risk factor, particularly in relation to allergic disease and
asthma. In the United States alone, over 50 million people suffer from allergies each year, with an estimated annual cost
of over $18 billion. Although numerous contaminants have been identified indoors, mitigation in most cases is possible
because their sources, chemical characteristics, dissemination, and health effects have been identified. Contaminants that
tend to be particularly challenging to manage are those that either remain un-identified or that we do not fully understand.
Bed bugs have resurged globally during the last 20 years, severely affecting the quality of life in disadvantaged
communities. I recently discovered and quantified large amounts of histamine in bed bug-infested homes. Although
histamine has been extensively investigated as a food contaminant in fish and alcoholic beverages, chronic exposure to
histamine has not been considered because histamine has never been detected as a contaminant in homes. Histamine is
a downstream modulator in the mammalian immune response, and it is routinely used in provocation tests, including
bronchial challenge and skin tests. The presence of large histamine deposits in household dust and its multiple clinical
effects (e.g., vasodilation, inflammation, neuromodulation) predict that dermal and respiratory exposure to histamine
could constitute a serious health risk. I therefore hypothesize that histamine is ubiquitous in bed bug infested homes,
particularly in inner-city low-income residences, and chronic exposure to histamine poses serious health risks to humans.
I propose an integrated and interdisciplinary approach to understand the contribution of bed bugs to histamine residues
in homes, the pervasiveness and spatial distribution of histamine in the indoor environment, and the effects of histamine
on human health. If successful, this project will identify a new environmental contaminant that has gone undetected and
unabated for almost two decades. To this end, I will address the following specific aims:
1. Quantify bed bug histamine production and determine the extent of histamine production in other arthropods.
2. Characterize the spatial distribution of histamine in bed bug infested homes.
3. Correlate environmental histamine with the bed bug resurgence and adverse health outcomes
4. Determine the bioactivity and clinical relevance of bed bug derived histamine
Presently, no programs offer the opportunity to conduct cutting edge research at the intersection of indoor entomology
and public health. Therefore, to address the problems outlined above, I require research independence. This award,
supported by significant commitments from my host institution, will provide me with the infrastructure and mentoring to
rapidly develop into an independent researcher. I am well-prepared to bypass the traditional post-doctoral phase because
of my experience working on projects that span several levels of biological organization, my leadership in international
collaborative projects, mentorship of several undergraduate students, strong publication record, and my proven ability to
coordinate large-scale multi-disciplinary studies. The experience I have gained and my productivity during my graduate
training surpasses what many scientists achieve during the first 3–5 years of post-doctoral training.

Public health relevance
Allergies affect more than 50 million people in the United States, with estimates of health costs exceeding $18 billion annually. Central to combatting allergic disease and asthma are efforts to understand the environmental risk factors that induce allergic responses. This project, stemming from my recent discovery that bed bugs disseminate large amounts of histamine in their feces, will comprehensively document the prevalence and distribution of histamine in homes infested with bed bugs and determine the risks of exogenous histamine exposure to human health, both of which are critical to promote human health and well-being in the indoor environment.